MYRF as an Entry Point to Study Mesothelium Function in Lung Development and Injury Repair

PROJECT SUMMARY/ABSTRACT
The mesothelium is an overlooked cell type that is also ubiquitous: it is the most external cell layer that
encapsulates all internal organs and lines the body cavities. The best-known canonical function of the
mesothelium is to produce lubricant to facilitate organ sliding past each other and the body wall. The
mesothelium is composed of a single layer of large and flat squamous epithelial cells that is derived from the
mesoderm lineage. In the lung, aside from being the site of asbestos-induced mesothelioma, the role of this
fundamental cell layer in lung development and injury repair is poorly understood, and is the focus of this
study.
Our entry point to studying the mesothelium is Myelin Regulatory Factor (MYRF), a transcription factor.
Variants in the MYRF gene have been identified in congenital diaphragmatic hernia (CDH) patients. CDH
carries a high mortality rate at birth largely due to respiratory distress. In the lung, MYRF is expressed in the
mesothelial cells and alveolar type I cells, two large and flat cell types of the mesenchyme and epithelium,
respectively. In mice, while inactivation of Myrf in the lung epithelium led to no discernable phenotypes,
inactivation of Myrf in the mesenchyme led to a clear CDH phenotype, including organ herniation, lung
hypoplasia and lethality at birth. Later inactivation of Myrf bypassed embryonic lethality, revealing a striking
subpleural fibrosis phenotype in the postnatal lung. In the adult, bleomycin treatment of these mutant lungs led
to exaggerated injury compared to control, implicating subpleural myofibroblasts as a possible contributor to
fibrosis progression. In this study, we will use MYRF as an entry point to investigate mesothelium function as a
signaling center in lung growth (Aim 1), as an active barrier in homeostasis (Aim 2), and as an instigator of
pathogenesis in lung repair (Aim 3). Our findings will delineate the fundamental role of the mesothelium and its
quintessential transcription driver MYRF in lung development, homeostasis, injury and repair.

Public health relevance
NARRATIVE The human lung, similar to other internal organs, is encapsulated by a thin squamous epithelium called the mesothelium. Aside from knowledge that mesothelial cells produce lubricating fluid to facilitate smooth organ movement in relationship to each other and the body wall, mesothelium function in lung development and injury repair remains poorly understood. In this study, we will use Myelin Regulatory Factor, a transcription factor that is expressed in the mesothelium as an entry point to address the formation of this fundamental cell layer, its role as a signaling center in lung growth, and its crosstalk with other injured cell types in lung repair.